Rapid Non-invasive Radiation Biodosimetry through Metabolomics

Project 3 focuses on the development of metabolomic signatures of past radiation exposure in biofluids
such as urine and serum. These biomarkers are particularly useful because of the potential for non invasive
sample acquisition and the long metabolomic signal lifetime - days or weeks after exposure. Metabolomic
signatures developed to date have been predictive of both dose and late health outcome. The themes here are
“Beyond Simple Exposures”, “Beyond Dose”, “Beyond Model Systems” and “Optimized Biomarker Integration”,
which are motivated by the variety of different exposure scenarios and countermeasure needs.
Beyond Simple Exposures: While most radiation biodosimetry studies have involved photons at intermediate
dose rates, realistic exposure scenarios to which individuals will be exposed after an IND may include: mixed
neutron+photon exposure, very high dose rates, variable low dose rates, and partial body exposure. This
CMCR uses unique irradiation facilities designed to simulate these exposures, and these will be used to
assess if a reference metabolomic signature can reconstruct the dose - or if additional metabolites are required
to identify different exposure scenarios.
Beyond Dose: Metabolomic biomarkers have been useful not only for reconstructing past radiation dose but
also for predicting photon-induced pulmonary death. Here these predictive capabilities will be assessed
following mixed neutron+photon exposures. Mechanistically, a focus will be on radiation-induced senescent
cell signaling, which is a likely player in the development of late pulmonary injury. The contribution of radiation-
induced senescent cell signaling will be evaluated in photon vs. mixed neutron+photon induced late lung
injuries, and how it affects the predictive signature of these injuries.
Beyond Model Systems: In that most biodosimetry studies are of necessity conducted in animal models, this
theme addresses the link between metabolomic biomarkers of radiation exposure in animals vs. humans.
Although many relevant exposures cannot be directly investigated in humans, samples from photon-exposed
TBI patients can help guide the translation of biodosimetry assays from animal models. A very large
metabolomic database from TBI patients, mice, and NHPs will be analyzed to test the hypothesis that there is
a common radiation-responsive metabolomics signature across all three species.
Optimized Biomarker Integration: The three different biomarker systems in this CMCR program
cytogenetics, gene expression, and metabolomics reflect different balances of capabilities in terms of
throughput, time-to-result, dose reconstruction, exposure scenario identification and radiosensitivity prediction.
Our common goal is to identify their optimal integrated usage in a wide variety of different large-scale exposure
scenarios. As results emerge from this Project, they will be used as input to optimize decision trees to
determine which assay, or combination of assays, will be most effective in each radiation event scenario.